Modeling cochlear micromechanics and noninvasive measures of cochlear function

PROJECT SUMMARY
Normal hearing requires amplification of the cochlear response to low-level sounds through a mechanism known
as the cochlear amplifier, which is closely tied to the electromechanical feedback from outer hair cells; however,
our understanding of the mechanisms underlying cochlear amplification is still incomplete. Recent in vivo
experiments have revealed that the micromechanical vibrations of the organ of Corti are influenced by outer hair
cells in intricate and unexpected ways. Hydrodynamic coupling between the organ of Corti vibrations and the
intracochlear fluid, which plays a role in cochlear amplification, is not well understood. In addition to facilitating
the detection of low-level sound, the feedback from outer hair cells gives rise to measurable sounds in the ear
canal called otoacoustic emissions. While otoacoustic emissions are not known to play any functional role, they
provide highly valuable noninvasive information about cochlear amplification and health, including for clinical
hearing screening. However, the precise connection between the micromechanical vibrations of the organ of
Corti and otoacoustic emissions remains unclear, which hampers the ability of otoacoustic emissions to
accurately locate cochlear damage for noninvasive diagnosis. Measurements of the cochlear microphonics (an
electrical potential generated by outer hair cells) at the round window can also provide information about cochlear
function but are limited in part by the lack of understanding of electrical coupling within the cochlear ducts.
The overall objectives of this project are to advance knowledge regarding the key mechanisms of active cochlear
mechanics and to clarify the potential of noninvasive measurements (specifically, otoacoustic emissions and
round window cochlear microphonics) in offering valuable insights into cochlear function. This research is based
on the development of novel, physiologically motivated computational models of the inner ear. These models
are specifically designed to address crucial questions in cochlear mechanics highlighted by recent experimental
findings. Throughout the project, models will be calibrated, validated, and tested using data from relevant
literature and new experiments. Aim 1 will assess the impact of hydrodynamic fluid coupling to the upper surface
of the organ of Corti on cochlear amplification. Aim 2 will determine the roles of two distinct mechanisms in giving
rise to longitudinal motion of the organ or Corti. Aim 3 will evaluate the link between micromechanics of the organ
of Corti and non-invasive measures based on round window cochlear microphonics and otoacoustic emissions
using a high-fidelity model of cochlear electro- and hydro-mechanics.

Public health relevance
Project narrative This project will advance fundamental knowledge regarding how the healthy inner ear responds to sounds, which is essential for normal hearing. The research will also improve understanding of how the ear generates sounds, which are commonly used for noninvasive hearing screening. The fundamental insights gained from this research will facilitate the improvement and development of innovative techniques for the diagnosis and treatment of hearing loss.